Administrative Core

ABSTRACT: ADMINISTRATIVE CORE
The success of the Yale Center for the Study of Tobacco Products (YCSTP) requires coordinated efforts at
many levels. In a role similar to its function for TCORS 1.0 and 2.0, the Administrative Core will provide the
centralized oversight required to effectively and efficiently run the Center’s primary Projects and pilots.
The Administrative Core also will ensure productive collaboration both within the YCSTP and with external
partners including the FDA, the TCORS Coordinating Center, and other TCORS. To carry out its duties, the
Administrative Core has five specific aims: 1) to provide scientific oversight and monitoring of YCSTP activities
internally via the YCSTP Executive Committee (Project/Core Leads and NIDA/CTP liaisons) and in
consultation with our center’s Data Safety and Monitoring Board, Scientific Advisory Board, and Community
Advisory Board, 2) to manage Center activities related to progress through coordinating timely training of
research staff on central study assessments as well as participant recruitment and retention, monitoring safety,
and submitting biannual reports on the progress of all projects, 3) to manage and share data by creating and
maintaining datasets for internal use and preparing limited and/or public datasets for external use, 4) to provide
oversight of regulatory, fiscal, and dissemination activities to ensure that YCSTP resources are used
appropriately and efficiently and that findings are disseminated through a variety of sources including docket
submissions, press releases, academic presentations and publications, and presentations within the
community, and 5) to facilitate communication and collaboration within the Center and with NIH, FDA, the
Coordinating Center, and other TCORS. Overall, the activities of the Administrative Core are essential to
supporting the timely completion of the proposed research and providing the FDA-CTP with the evidence
required to support the regulation of tobacco products. As in TCORS 1.0 and 2.0, the Administrative Core will
be led by the PIs for the YCSTP, Drs. Suchitra Krishnan-Sarin and Stephanie O’Malley.